Research and Mentoring Program in Improving Access to Incontinence Care for Older Adults

PROJECT SUMMARY
This application for a K24 Midcareer Investigator Award will promote Dr. Alayne Markland’s mentoring and
career development in patient-oriented research on lower urinary tract symptoms and urinary incontinence at
the University of Alabama at Birmingham (UAB). Dr. Markland is a geriatrician and clinician investigator
dedicated to advancing evidence on the prevention, evaluation, and treatment of bladder and bowel symptoms
for older women and men. With funding from the National Institute on Aging, the National Institute on Diabetes,
Digestive, and Kidney Diseases, and the Department of Veterans Affairs, she leads a nationally recognized,
patient-oriented research program that emphasizes improving access to care models, as well as improving
knowledge on shared risk factors underlying aging-associated genitourinary dysfunction. Her work focuses on
the intersection of common aging syndromes, such as depression and functional status, with lower urinary tract
symptoms and incontinence. To date, she has created new models of care for women and men, improved
patient-reported outcome measures used in clinical care and research and provided evidence to guide national
and international guidelines on the treatment of lower urinary tract symptoms and incontinence. She has also
emerged as a successful mentor of early-stage clinical investigators who have published high-impact research,
obtained NIH and VA-funded awards, and continues to improve patient-oriented research focused on
behavioral interventions.
With award support, Dr. Markland plans to expand and refine her mentoring skills through didactics and
focused training, and to continue mentoring her current early-stage trainees and recruit new trainees with a
focus on female trainees from diverse backgrounds. All trainees will be provided with educational and research
experiences tailored to their career stage and interests. With award support, Dr. Markland’s research program
will be augmented through a newly funded clinical trial addressing the use of mobile health platforms to deliver
behavioral treatments for lower urinary tract symptoms and incontinence care, which will provide new
opportunities for mentoring trainees, collaborations, and future funding. The Aim of New Study 1 is: Identify
mechanisms by which behaviorally based mobile health platforms improve lower urinary tract symptoms and
incontinence severity. The Aim of New Study 2 is: Define barriers and facilitators for using mobile health
technology for improving lower urinary tract symptoms and incontinence severity. The Aim of New Study 3 is:
Determine effective, feasible candidate components for future mobile health interventions. The long-term goal
of Dr. Markland’s research and career is two-fold: 1) to become a leader of behaviorally-based treatment
interventions with digital health platforms, and 2) to enhance skills as a mentor of patient-oriented research —
particularly for women and minority mentees. Through this award and the new research studied proposed, Dr.
Markland will support high-quality mentees with the potential to become leaders in patient-oriented research
related to aging and lower urinary tract symptoms/incontinence.

Public health relevance
PROJECT NARRATIVE Dr. Markland is a midcareer physician scientist in the field of geriatrics who has established a federally funded lower urinary tract symptoms/incontinence research program and a record of accomplishment for mentoring early-stage clinical investigators. This midcareer mentoring award will enable Dr. Markland to develop and refine her mentoring skills, continue providing patient-oriented research mentoring to early-stage trainees, and expand her research program in new directions by supporting new patient-oriented research. The proposed projects will build upon an existing mobile health technology platform designed to deliver behaviorally based treatments for lower urinary tract symptoms/incontinence and improve our understanding of factors that impact response to treatments. Mentoring provided should advance the research careers of many early-stage investigators while also improving response to treatments.